Jump Start to Talk: Understanding Diverse Perspectives from Parents and Teachers to Rethink and Improve Identification, Referral, and Service for Dual Language Learner Late Talkers.

Background: Jump Start to Talk aims to understand culturally embedded perspectives of caregivers and early
care and education (ECE) teachers from Spanish- and Haitian Creole-speaking communities regarding late
talkers (LTs) who are dual language learners (DLLs). Using a dual-community comparative approach to examine
both Hispanic and Haitian populations, this study addresses critical gaps in understanding LTs who face risks of
persistent language delays and poor academic outcomes, heightened for DLLs due to misidentification and
cultural-linguistic service access barriers. Approach: Using Israel et al.'s community-based participatory
research (CBPR) approach, we will leverage partnerships between the University of Miami and three local
organizations: Sant La Haitian Neighborhood Center (urban), Le Jardin Hispanic Community Center (rural), and
Speech Pathology Educational Center (SPEC), serving families in both communities. We will co-design and co-
implement the study with these community partners and their cultural brokers - trusted community members who
share participants' linguistic and cultural backgrounds. Through purposive sampling of our network of 75 ECE
centers serving Hispanic and Haitian families, we will identify 30 LT DLLs using culturally and linguistically
appropriate screening approaches. We will interview their caregivers and 30 ECE teachers. Applying Sapiets et
al.'s service access model and using the Framework Method for qualitative analysis, we will co-analyze interview
data with our community partners to understand factors influencing service access from identification to
provision, addressing two aims: Aim 1: Recognition and Identification of Late Talking: What are the perceptions
of caregivers and teachers from two underserved communities regarding a) how they recognize and understand
typical versus delayed language development in DLLs, and b) what factors influence their decisions about
seeking services? Findings will directly inform development of culturally and linguistically appropriate
assessment tools for identifying LTs in DLLs. Aim 2: Early Support Service Access: What barriers and facilitators
do caregivers and teachers from two communities experience when attempting to access and engage with early
support services (ranging from preventive monitoring and classroom-based supports to formal early intervention
programs, community-based services, and parent-implemented language support strategies) for DLL LTs?
Impact: These aims meet a high-priority research area for NICHD PAR-24-046 by examining identification and
referral processes for LT DLLs from Spanish- and Haitian Creole-speaking backgrounds. The innovative dual-
community approach and use of cultural brokers will inform the development of culturally responsive screening
and referral processes, particularly addressing the needs of Haitian Creole-speaking communities where
validated measures are currently lacking.
.

Public health relevance
Jump Start to Talk will examine how caregivers and early care and education teachers from Spanish- and Haitian Creole-speaking communities recognize late talking in dual language learners and navigate early support services, comparing experiences between these cultural-linguistic groups. Leveraging cultural brokers from Sant La Haitian Neighborhood Center, Le Jardin Hispanic Community Center, and Speech Pathology Educational Center, we will conduct native-language interviews to explore barriers and facilitators to identification and service access. Results will inform development of culturally responsive assessment tools and service pathways— particularly for Haitian Creole-speaking communities where validated measures are lacking—ultimately supporting an R01 application to validate these approaches.